Activating gasdermin pores to induce pyroptosis and stimulate anti-tumor immunity

Cancer immunotherapy using checkpoint blockade (CPB) has revolutionized cancer treatment,
providing durable cures with acceptable toxicity in some cancer patients. However, only a few
cancer types respond and even in responding tumor types, response is often limited to a minority
of these cancers, which raises the question whether directly targeting T cells is sufficient and
whether other aspects of immunity can be exploited to stimulate or boost antitumor immunity.
Inflammatory, or immunogenic, cell death is emerging to be an important immune node that
bridges innate and adaptive immunity to stimulate antitumor immunity as well as to potentiate
CPB. While antineoplastic agents currently used in humans can also sometimes induce
inflammatory cell death to help re-establish immune surveillance in the tumor microenvironment,
these agents do not predictably induce immunogenic cell death, thus leading to variable outcomes.
The hypothesis we propose in this project can fundamentally change this scenario by
inducing predictable immunogenic cell death through targeting key molecules known as
gasdermins (GSDMs) in particular GSDMD, which are widely expressed in cancers and can
directly induce immunogenic cell death upon activation. GSDMD mediates pyroptosis and
cytokine release downstream of inflammasomes, which are supramolecular complexes that
activate inflammatory caspases (caspase-1/-4/-5 in humans, caspase-1/-11 in mice). Activated
caspase-1 processes IL-1 family cytokines to their active forms and all inflammatory caspases
cleave GSDMD to produce an N-terminal (NT) fragment that forms pores in the cell membrane to
induce pyroptosis, and to release IL-1 family cytokines and other inflammatory mediators,
including ATP and HMGB1.
We specifically propose to identify small molecule agonists of GSDMD for direct induction
of immunogenic pyroptosis in cancer cells, which may also synergize with other immune
modulators as well as with CPB. GSDMD is widely expressed in cancers. While GSDMD is also
expressed in some normal tissues, the need for only a small fraction of tumor cells to undergo
pyroptosis to alert the immune system may make GSDMD agonism non-toxic even when
administered systemically.

Public health relevance
GSDMs are associated with many human diseases, and deletion of GSDMD significantly decreases pyroptosis and IL-1β secretion, and remarkably protects mice from sepsis. By contrast, activation of GSDMs enhances pyroptosis and may promote anti-tumor immunity. Thus, identification of small molecule GSDM agonists to “engineer” tumor cell death for antigen presentation and for priming the adaptive immune system will have significant impact on potential therapeutics against cancer.